Discovery and Developmental Therapeutics Research Program

The Discovery and Developmental Therapeutics (DDT) Program accelerates discoveries that drive cancer
diagnosis, detection, drug delivery, and therapeutic approaches with the premise that multidisciplinary
interactions among DDT members will advance highly innovative anti-cancer strategies. The program includes
three scientific themes: (1) Discovery, the discovery and evaluation of therapeutic targets and novel small
molecules; (2) Cancer Imaging, the development and/or utilization of in vivo imaging agents and technologies
for non-invasive diagnostic/therapeutic cancer applications; and (3) Developmental Therapeutics, human
interventional cancer trials using novel therapies and individualized treatment options by functioning as a
convergence point for translation of targets, imaging, therapeutic agents, and immunotherapies. The productive
bench to bedside research of DDT members furnishes a rich training environment for the next generation of
cancer researchers with activities to promote biomedical science careers of program members. Strong
engagement with Community Outreach and Engagement (COE) drives prioritization of catchment area needs in
DDT programming and member research. The three scientific themes with COE priorities guide the program’s
activities and intra- and inter-programmatic research. Under the leadership of Haian Fu, PhD (leader) and Kelly
Goldsmith, MD (co-leader) the DDT Program includes 55 core members from 13 different Emory departments
who published a total of 1,272 cancer-relevant scientific articles during the current funding period. Of these,
420(33%) were intra- and 373(29%) were inter-programmatic collaborations; 898 (71%) involved a collaboration
with another cancer center or academic organization and 354(28%) were published in journals with an impact
factor ≥10. As of December 31, 2021, DDT members held $20.4 million (direct) in annual cancer-relevant
research funding, of which $6.9 million is peer-reviewed with $4.5 million (65%) from the NCI. Notable new team
science funding includes the NCI P50 Lung SPORE (MPI: Ramalingam, Fu), successful renewal of NCTN Lead
Academic Participation Site Award (UG1CA233247) in 2019 (MPI: Higgins, Saba, Staley), one of twelve NCI/VA
Navigate awards (Harris) to promote clinical trials accruals at the Atlanta VA medical center, and NCI Cancer
Target Discovery and Development (CTD2) network award (U01CA217875). Impactful DDT scientific
contributions over the past funding cycle include: i) Discovery and development of MER-TK inhibitor MRX-2843
into a first in human Phase I clinical trial, ii) DDT discovery to FDA approval of radiopharmaceutical fluciclovine
for recurrent prostate cancer, iii) FDA approval of Abatacept for acute graft versus host disease prevention and
iv) leadership of multiple NCTN trials including Phase III trials that ushered in new treatment paradigms for
cancer. Built on Winship’s enabling resources and infrastructure, including $1.7M in pilot funding, the DDT
Program is making major contributions to the development of diagnostic and treatment approaches for cancer
patients in the catchment area and beyond.